Weinstein Cardiovascular Development Conference

DESCRIPTION (provided by applicant): The specific aim of this proposal is to obtain partial funding to support the Weinstein Cardiovascular Development Conference. This meeting will be held in Tucson, Arizona in 2013, in Madrid, Spain in 2014, and in Boston, Massachusetts in 2015. The annual Weinstein Conference is the premier meeting in the field of cardiovascular development and disease. The meeting evolved from annual meetings of investigators funded by RFAs on cardiovascular development offered through NHLBI in the late 1980s. It is entirely research community driven, with several features that make it unique among scientific conferences. The objectives of each meeting are to bring together basic and clinical scientists working in the areas of cardiovascular biology, to provide an interactive forum for students, postdocs and junior investigators to present their work and interact with senior investigators, and to actively support diversity in science. Funds are requested to: 1) Reduce student registration fees, 2) Provide financial assistance for underrepresented groups, and 3) Support general meeting obligations.

Public health relevance
Funds are requested for partial support of the Weinstein Cardiovascular Development Conference, the premier annual scientific meeting in the area of cardiovascular development, disease and repair. Congenital heart defects and heart disease are among the most widespread and costly health issues in the United States and worldwide. The Weinstein Conference brings together clinical and basic scientists to discuss the latest findings about the underlying causes and potential cures for cardiovascular abnormalities and disease.